Label-free fluorescence lifetime imaging for intraoperative real-time guidance of neurological procedures

PROJECT SUMMARY/ABSTRACT
The outcome of brain tumor surgery is critically dependent on the neurosurgeon's ability to distinguish between
abnormal and normal tissue in real-time. Our goal is to enhance this discrimination by using label-free
Fluorescence Lifetime Imaging (FLIm) to detect tissue biochemical and metabolic characteristics that distinguish
among different tissue types and, by integrating FLIm into the neurosurgical workflow, to provide this information
in a real-time, visual format useful for guiding tumor biopsy and resection. FLIm-derived tissue fluorescence
feature information will be co-registered with the preoperative-MRI (pMRI) and projected onto the conventional
surgical microscope field-of-view (FOV). This should improve delineation of tumor margins and thus increase
both the diagnostic yield of brain biopsy and the extent of tumor resection.
The proposed FLIm technique will incorporate the following features: (1) Safe, rapid, and simultaneous
measurement of time-resolved fluorescence decays in multiple spectral emission bands that will acquire
extensive information in one scanning measurement of a large area of tissue selected by the surgeon; and (2)
Fast analysis, display, and augmentation of fluorescence parameters that enable real-time visualization of optical
data encoding diagnostic information onto the surgical FOV. The proposed clinical studies using FLIm as a stand-
alone tool will establish classifiers to correlate FLIm parameters with specific tissue pathologies, an important
step in demonstrating FLIm's diagnostic value. The proposed integration of FLIm as an adjunct to the
neuronavigation system and surgical microscope will provide data for combined analysis to validate the benefit
of FLIm diagnostics in neurosurgical procedures. Three aims are proposed: Aim 1) Construct and integrate a
FLIm device as a diagnostic adjunct with conventional neurosurgical tools. Aim 2) Clinically evaluate the
relationship between FLIm parameters and distinct tissue pathologies and develop classifiers for different tissue
types. Aim 3) Validate FLIm for real-time intraoperative guidance through a prospective analysis.
In summary, this study will demonstrate the clinical feasibility and utility of FLIm for intraoperative real-time
assessment of neurosurgical margins and the resulting improvement in neuropathologic diagnostic yield. The
acquired FLIm parameter database will enable subsequent clinical trials for automated tissue classification and
diagnostic prediction. The new FLIm instrumentation, characterized by simple, fast and flexible data acquisition
and display, and its seamless integration with existing neurosurgical imaging, will provide a less expensive
alternative to intraoperative MRI and a valuable complement to current standard-of-care diagnostic procedures.
Success in this area will warrant a more generalized use of FLIm in surgical oncology (other cancers) as well as
guided interventions for treatment of functional neurologic diseases (e.g. epilepsy, neurodegenerative diseases).

Public health relevance
PROJECT NARRATIVE The success of brain tumor resection and biopsy is limited by the surgeon's ability to distinguish pathologic from normal tissue intraoperatively and in real-time. Our novel optical imaging FLIm system captures and analyzes tissue autofluorescence to identify distinct brain tissue types (tumor, necrotic, normal) and integrates this information with standard of care neurosurgical technologies for convenient display onto the surgeon's field-of- view, providing a means to better acquire a robust diagnostic biopsy and achieve maximal tumor resection. The successful validation of FLIm as an intraoperative adjunct for tumor tissue identification will improve brain cancer patient outcomes and generate a paradigm for the use of FLIm in multiple areas of surgical oncology (other cancers) as well as guided interventions for treatment of functional neurologic diseases.